Enhancing Nursing Care Reliability in Neonatal Intensive Care Units

Project Summary/Abstract Not applicable for supplement application

Public health relevance
Narrative Not applicable for supplement application